Circulating and Brain Lipidomics, Cognition and Dementia

Decline in cognition and the onset of Alzheimer’s disease (AD) and dementia impose a devastating personal
and interpersonal burden with huge societal costs. To provide insights into new mechanisms and identify
novel targets to prevent AD, dementia and cognition decline, we propose a comprehensive study of plasma
and brain lipidomics species and incident AD, dementia and cognition. Lipids are thought to be involved in
AD however most studies have examined overall fatty acid composition or total levels of a lipid class without
regards to fatty acids. Precise identification of lipid species with their fatty acid chains is needed to discover
pathways and new mechanisms involved in AD, potentially resolve prior inconsistent reports, and provide
critical information on novel targets to prevent AD and cognition decline. We will leverage the novel Lipidyzer
technology that can quantitate 1500 lipids with identification of their separate fatty acid chains to measure
lipidomics species in 1) existing plasma specimens in a large prospective cohort, the Cardiovascular Health
Study (CHS), and 2) postmortem brain samples from AD patients and controls from the Johns Hopkins
University Brain Resource Center (BRC). We will examine the association of plasma lipidomic species with
risks of incident AD, incident total dementia, and cognition decline in 3868 participants in CHS, a prospective
cohort of older European and African ancestry men and women (Aim 1). In addition, we will examine the
associations of the lipidomic species identified in Aim 1 with modifiable risk factors including dietary factors,
physical activity, tobacco use, and medications to guide future interventions. Complementing the study of
circulating lipids, we will measure lipidomics species using the same technology in postmortem brain samples
from frontal and occipital neocortices from 570 patients, including 350 with AD dementia, 40 with mild
cognitive impairment (MCI), 15 asymptomatic with β-amyloid (Aβ) deposits and tau/neuritic plaques
(neurodegeneration), 45 asymptomatic with Aβ deposits only, and 120 controls without cognitive impairment
and without Aβ deposits (Aim 2). We will identify lipids that differentiate the AD brains from the normal brains,
carefully adjusting for the cell composition of the samples; and we will identify lipids that mark the transitions
from normal brain to Aβ deposits, to tau/neuritic plaques in asymptomatic patients, to MCI and to overt AD.
We will also examine whether the lipidomics signatures identified in Aim 2 are associated with cognitive
decline and dementia risk in the CHS cohort and vice versa. With the combination of these two powerful
approaches and a novel method to precisely measure lipids with their fatty acids, the study is poised to deliver
new targets for the prevention of dementia, AD and cognitive decline.

Public health relevance
NARRATIVE The aim of this study is to identify novel circulating lipids associated with the risks of Alzheimer’s disease, dementia and cognitive decline. The research is conducted in the Cardiovascular Health Study, a cohort of older adults as well as using postmortem, well phenotyped brain samples from patients across the spectrum from normal to diagnosed Alzheimer’s disease. This research, which takes advantage of a novel technology to measure up to 1300 lipidomics species, will provide new targets for future interventions to reduce risks of dementia and cognitive decline.